Assessing Bone Health after SCI: Establishing Evidence for a Clinical Protocol

The Veterans Health Administration (VHA) is the largest single provider of heath care to individuals with
spinal cord injury (SCI) in the United States. For 2016, Paralyzed Veterans of America estimates that 43,000
veterans with SCI received care from VHA. The annual cost of that care is substantial. In 2015, the total costs
during the first year following an SCI ranged from $520K to $1.1M; recurring costs ranged from $69K to $185K
per patient per year. Lifetime costs also continue to increase as life expectancy post-SCI increases. A key
contributor to the high medical cost post-SCI is fragility fracture, often requiring prolonged hospitalization and
specialized care. Up to three-quarters of individuals with SCI will sustain a fragility fracture in their lifetime.
Fractures lead to serious medical complications, a loss of independence, and a loss of productivity, all resulting
in substantial direct and indirect costs. SCI clinicians and patients agree that maintaining an active lifestyle is
critical not only for general health, but also for musculoskeletal health. Given the substantial loss of bone that
occurs in the lower limbs following SCI, however, clinicians must always be cognizant of the possibility of
fracture, especially for those with more chronic injuries.
Bone mineral density (BMD) measurement from a Dual-energy X-ray Absorptiometry (DXA) scan is the
clinical gold standard for osteoporosis assessment in able-bodied individuals. Accurate diagnosis is important
since it guides treatment and it helps to inform patients and doctors what activities can and can't be performed
safely. Unlike the case with able-bodied individuals, there is no clinical standard and no consensus for
assessing skeletal health in the lower limbs of individuals with SCI. For able-bodied individuals, the standard
sites for scanning are the spine and hip, which are common sites of fracture in those with age-related
osteoporosis. For those with SCI, however, most fractures occur just above and just below the knee. Hip and
spine BMD are not good predictors of fracture at distal sites in the legs and, at present, no standardized
protocols exist for assessing skeletal health near the knee. SCI clinicians continue to be faced with a critical
question which is: Is it safe for my patient to participate in certain rehabilitation activities, recreation and sports
activities, or to use an exoskeleton for ambulation? Currently, there is no evidence-based answer to that
question. The purpose of this project is to validate scan protocols for bone mineral density assessment that will
enable clinicians to address that issue. This in turn will allow clinicians to prescribe and monitor rehabilitation
therapies and recreational activities that are appropriate for a particular patient given his or her skeletal heath.
Over the past three decades more than a dozen different protocols have been proposed for scanning the
area above and below the knee in patients with SCI, including nine protocols introduced since 2005. Those
protocols have not been comprehensively assessed or compared for sensitivity or precision, nor have
normative, reference values been determined for able-bodied individuals. Our study has four Specific Aims.
Aim 1 is to generate normative databases for the multiple DXA protocols that have been proposed for bone
density scanning of the distal femur and proximal tibia. Aim 2 is to determine and rank the precision of those
protocols in able-bodied individuals. Aim 3 is to the determine precision for the knee DXA protocols examined
in Aim 1, but in individuals with SCI >4 years post-injury, and to see if High-Resolution QCT and peripheral-
QCT scanning provide clinically valuable complementary data compared to DXA. Aim 4 is to measure bone
changes over time in patients 1 to 4 years post-injury and, for DXA, to compare those changes to the least
detectable change determined from the precision for each candidate knee DXA protocol. The results of this
study will have immediate clinical utility and will lay the groundwork for future development of a fracture risk
assessment tool specific for persons with SCI, comparable to risk assessment tools already available for able-
bodied individuals. Clinical implementation of validated DXA protocols will be the immediate next step.

Public health relevance
The VA currently provides care for approximately 43,000 veterans with spinal cord injury (SCI), making it the single largest provider of care to patients with SCI. Up to three-quarters of individuals with SCI will sustain a fragility fracture in their lifetime. Half of patients who fracture will experience a serious medical complication. Fracture is a constant concern as seemingly innocuous activities such as joint range of motion exercises and transfers can result in fracture. SCI clinicians have neither evidence-based nor consensus guidelines for assessing skeletal health at the most fragile sites for patients with SCI. As a result, physicians must rely on experience and clinical judgment, rather than data, when recommending whether it is safe for a patient to participate in traditional rehabilitation activities, sports, or when using emerging technologies such as exoskeletons. The goal of the proposed study is to alleviate those shortcomings. Given the long history that VA has played in the care of individuals with SCI, we believe that the field will gain significantly from this research.